Protocadherin 7 and Osteoclast Maturation

Inflammation is known to cause bone destruction by excessive osteoclast (OC) activity in patients with
inflammatory diseases, such as periodontitis. To address the underlying causes of such inflammation-­related
bone loss, it is important to understand how the cellular and molecular mechanisms of bone homeostasis
maintained by bone-­forming osteoblasts (OBs) and bone-­resorbing OCs are perturbed by inflammatory stimuli.
Targeting OC maturation rather than differentiation is of particular interest and provides an added benefit of
avoiding unintentionally inhibiting new bone formation. However, identifying promising therapeutic targets of
OC maturation will require greater understanding of its mechanisms of regulation. Cell adhesion is a
physiologic process critical to both OC maturation and its hallmark feature, multinucleation. In the course of
screening potential genes that regulate OC maturation in vitro, we identified a cell adhesion-­related gene,
Pcdh7, a protocadherin member of the cadherin superfamily. We have now generated Pcdh7-­/-­ mice for the
purpose of further studying Pcdh7 in OC maturation and inflammatory responses, and therefore propose the
following specific aims: 1. Investigate the role of Pcdh7 in OC differentiation, function, and inflammatory bone
loss. We will employ Pcdh7-­/-­ bone marrow (BM) cells to examine expression of known biological markers and
cell biological functions, including adhesion, motility, actin ring formation, ruffled border formation, and vesicle
trafficking. Pcdh7floxed mice and BM chimeras will be generated for the purpose of more precisely interrogating
OC-­ versus OB-­specific (or other) Pcdh7 functions in the context of bone homeostasis. These mice will also be
employed to confirm the importance of OC-­expressed Pcdh7 in the context of inflammatory bone loss and
immune responses that occur after LPS treatment or ligature-­induced periodontitis. Together, these studies
should elucidate the cell-­specific roles of Pcdh7 in OC maturation and pathologic bone loss. 2. Investigate
mechanisms of Pcdh7 molecular function within OC biology. To investigate how OC-­expressed Pcdh7 protein
regulates cell adhesion and/or signal transduction, we will test a four-­step model. For each step, we will test
OC maturation, cell adhesion, and activation of signaling pathways, and will employ both physiologically-­
activated and hCD3-­inducible retroviral (RV) Pcdh7 constructs. First, we will test whether Pcdh7 mediates cell-­
cell interactions that activate Pcdh7 intracellular signaling by separately track WT and Pcdh7-­/-­ OCs in mixed
heterotypic OC cultures. Second, we will test the effects of cytoplasmic domain truncation isoforms of Pcdh7
by assaying physiologic expression in OCs and then by RV-­expressing isoforms in OCs. Third, we will test
whether and, if so, how Pcdh7 mediates intracellular signaling via the oncoprotein SET. Fourth, we will employ
siRNA and chemical inhibitors to test the relative contributions of Pcdh7-­dependent activation of various
signaling pathways to Pcdh7-­mediated OC adhesion and maturation. Together, these studies will improve our
understanding of the function of Pcdh7 protein generally, and more specifically, how it controls OC maturation.

Public health relevance
Inflammatory bone loss can be induced by excessive activation of bone-resorbing osteoclasts. Osteoclast activation is significantly affected by multiple membrane receptors and their intracellular signaling pathways. Understanding the molecular pathways that control osteoclast maturation and activation is required in order to properly treat inflammatory bone pathologies.